Using Meta-level Smartphone Data to Promote Early Intervention inSchizophrenia

Project Summary Using Meta-level Smartphone Data to Promote Early Intervention in Schizophrenia? Schizophrenia is one of the most debilitating disorders in the world today. It affects over 2.4 million adult Americans each year. NIMH director Dr. Thomas Insel has declared “The best chance for preventing serious functional disability among people with schizophrenia may be to intervene at the earliest stages of the disorder, at the first episode of psychosis or even before symptoms appear. However, to act before symptoms appear requires improved predictive capacity” (NIMH 2011 Budget). Creating tools to identify high-risk, `prodromal' individuals may be the single most important step towards developing effective interventions to reduce the duration of untreated psychosis (DUP), and thereby also reduce the morbidity and mortality associated with schizophrenia. Recent studies have shown that over 54% of individuals with schizophrenia are re-hospitalized within the first 12 months following their initial hospitalization. Even after the first hospitalization, preventing relapse and re-hospitalization may lessen the long-term severity of the illness. In this SBIR Phase I study, we propose to determine the feasibility of screening for prodromal individuals and individuals at high risk of relapse by applying interpretive algorithms to Passively Gathered Meta-level Smartphone Data (PGMSD). We hypothesize that PGMSD can effectively assist in screening for prodromal individuals who are progressing toward psychosis as well as for remotely assessing individuals at risk for relapse during the critical 12-month period following their first episode of psychosis (FEP). In Phase I, we plan to recruit 70 individuals who have been or are being evaluated at the Prodromal clinics at Columbia, UCSD, and UCLA, where an estimated 70 to 90% of clients already own Smartphones. Data gathered may include: the frequency of telephone calls, emails, and texts, to assess within person changes in social connectedness; GPS, accelerometer data, to assess physical activity, isolation, and sleep patterns. In the past, several IRB-approved studies have used smartphones for gathering similar data from patients. Algorithms will be developed using several techniques including machine learning to convert the meta-level data into measures of social functioning, physical isolation, physical activity, and sleep/wake reversals. In addition to achieving technological success, our goal in Phase I is to provide evidence of our ability to use PGMSD algorithms to differentiating group means of participants who are controls, prodromal, or experiencing their FEP (SIPS 1 or 2; 3, 4, or 5; or 6). In Phase II, we will further develop and validate these algorithms. If successful, the Phase II project will have a large and sustained impact as our algorithms will help (1) identify at-risk individuals who `are' or `are not' progressing toward conversion, (2) serve as an objective measure of treatment effectiveness; (3) give rise to clinical reports delivered to EHR systems that hold promise for preventing relapse during the critical 12 months after initial diagnosis, potentially reducing hospitalization and re-hospitalization rates.

Public health relevance
Project Narrative The proposed research protocol seeks to determine the feasibility of identifying individuals progressing toward a first psychotic episode or re-hospitalization by applying interpretive algorithms developed in part using machine learning to Passively Gathered Meta-level Smartphone Data (PGMSD) collected from the smartphones of 70 participants ages 18-30. If successful, the PGMSD-derived algorithms will assist in screening for prodromal individuals progressing toward psychosis as well as with remotely assessing individuals at risk for relapse during the critical 12-month period following their first episode of psychosis (FEP), potentially decrease hospitalization and re-hospitalization rates. This passive data gathering approach will augment existing active data collection approaches, aid clinicians in focusing on interpreting rather than gathering data from their clients, and could modify clinical paradigms by shifting treatment from individuals suffering from Schizophrenia to individuals who are at risk of developing psychosis with the goal of achieving `secondary' and eventually `primary' prevention.